Development of functional magnetic resonance imaging-guided adaptive radiotherapy for head and neck cancer patients using novel MR-Linac device

PROJECT SUMMARY/ABSTRACT
Delivering dose to cancers while sparing normal tissue is the ultimate goal in radiotherapy treatment,
especially in the head and neck. By identifying tumors which are more likely to respond early in treatment, as
well as subvolumes of resistant tumor, radiotherapy plans could be changed each day to take advantages of
biological alteration in the tumor, resulting in reduced side effects with equivalent probability of cure. Functional
imaging techniques, such as diffusion-weighted imaging (DWI) and intravoxel incoherent motion (IVIM), have
demonstrated utility in clinical series in discriminating early responders to radiation therapy in head and neck
cancers, as well as identifying radiation resistant disease post-therapy. These functional imaging techniques
could be utilized to actively adapt radiation therapy with high frequency during the radiation treatment course,
without requiring exogenous contrast or tracer administration.
The University of Texas M.D. Anderson Cancer Center, Elekta Medical Systems and Philips Healthcare
are jointly developing a combination imaging/therapy delivery device, which combines a 1.5 Tesla MRI with a
linear accelerator. The MR-LinAc device provides the capacity to acquire functional and anatomic imaging data
daily, in the treatment position, while simultaneously delivering radiotherapy.
The proposed project is a five-year technology development strategy that will ultimately result in a
unified workflow for quantitative functional imaging guided semi-automated dose modification during head and
neck radiotherapy. This project will implement state of the art simultaneous anatomic and DWI image
acquisition, spatially accurate dose and image registration, physical and digital phantom-based quality
assurance, software tracking of cumulative region of interest dose, serial tracking of apparent diffusion
coefficient (ADC) maps, and anatomic and functional imaging constraint based serial re-optimization. Finally,
we will leverage data from prospective head and neck cancer MRI clinical trials to validate and harden the
proposed imaging acquisition/quality assurance/software workflow in order to demonstrate clinical feasibility
and estimate potential for toxicity reduction and clinical utility.
Successful completion of this project will result in a method for monitoring functional imaging changes
to tumor and normal tissue daily during radiotherapy. This method can be used to generate data to assess the
dose to the organs and critical structures and can be used to maximize the dose to the tumor and/or minimize
the risk of complications to normal tissue. The resulting data can also be used to study dose-related treatment
side effects. The ultimate goal of utilizing this technology is to improve the delivery of radiotherapy treatments
and the quality of life of radiotherapy patients.

Public health relevance
PROJECT NARRATIVE Functional imaging with high field magnetic resonance imaging (MRI) provides non-anatomic information about tumor and normal tissue response to radiation therapy. This project aims to create an academic and industrial technology development partnership to develop functional imaging guided radiation therapy using a combination MRI/linear accelerator (MR-LinAc) device, allowing patients to have reduced side effects with equivalent or improved control of tumors of the head and neck.